Dynamic pattern formation in the cell cortex

Project Summary
The cell cortex--the outermost part of the cell including the plasma membrane and the
underlying cytoskeleton--is extraordinarily important for living systems. As the boundary
between the inside and outside of the cell, it must respond to an enormous variety of
intracellular and extracellular signals; as the primary motor of cell shape change, it must
be capable of rapidly reorganizing to drive diverse processes including cell division, cell
locomotion, and cell repair. The biological and medical importance of these cortical
capacities cannot be overstated: when functioning properly, they permit proper cell
division, morphogenesis, and damage responses; when functioning improperly, they
result in unwanted cell proliferation and metastasis, compromised development, and
deficits in cell and tissue repair.
Many essential cortical behaviors are controlled by the Rho GTPases which, in turn
control the cortical cytoskeleton. We have recently discovered that the Rho GTPases
and their upstream regulators exert their effects by virtue of their ability to self-organize
into periodic cortical patterns of GTPase activity including pulses, propagating single
waves, and propagating wave trains. These dynamic, self-organizing patterns are
evident in cells of both vertebrates and invertebrates and they direct cell division, cell
repair, and long-term cell shape changes. Here we will use new tools and approaches
to determine the rules that guide the formation of these patterns and to understand the
relationships between specific pattern features and the biological processes they
control. This work will provide fundamental insights into the diverse processes that
entail cortical reorganization and thus into the many pathologies that ensue when such
reorganizations are compromised.

Public health relevance
Project Narrative The cells in our body routinely reorganize their cortex--the outermost part of the cell. Such reorganization is required for cells to divide and to heal themselves and when it occurs improperly, serious diseases result. The proposed work will reveal the mechanisms responsible for cortical reorganization which, in turn, will permit better treatment of diseases that result from abnormal cortical reorganization.